NEW CHEMICAL PROBES ENABLE MASS SPECTROMETRY-BASED FOOTPRINTING OF HUMAN PROTEIN STRUCTURE IN LIPID MEMBRANES AND CELLS

Project Summary
Mass spectrometry (MS) based footprinting is emerging as a powerful means to answer biological questions
about membrane proteins (MPs), which participate in almost all physiological processes and represent more
than 60% of drug targets. This approach affords sufficient structural information for the dynamic, native
conformations and interactions of MPs in cells, which are beyond the reach of traditional structural methods (e.g.,
cryo-EM and crystallography). This bottom-up MS footprinting is complementary to but potentially more
informative than top-down native MS, which does not provide spatial resolution for MPs and is conducted in the
nonnative gas phase. Here we propose to continue development of novel MS footprinting methods in live cells
and native membranes. Our objective is to design, prepare, test, and improve chemical probes that provide high
footprinting coverage. We will then apply them to reveal drug interactions and cellular trafficking regulation of a
glucose transporter, GLUT1, a prominent anticancer drug target and a model MP representing ~ 25% of known
transport proteins. MS footprinting of MPs, however, poses three major challenges. 1) MPs, which are
hydrophobic and buried in lipid bilayers, are resistant to traditional probes (e.g., HDX, •OH radicals) that
penetrate poorly and give insufficient labeling. 2) Aliphatic side chains of transmembrane regions contain C–H
and C-C bonds that are unreactive with most chemical probes. 3) The footprinting needs to be conducted in cells
or membranes to maintain native conformation and interaction of MPs. Our hypotheses are: (1) Complementary
modifications of C-H and X–H bonds by free radicals produced photochemically and by nucleophilic reagents
maximize footprinting coverage. (2) Tuning the hydrophobicity of the reagents or their precursors allows access
to membrane-embedded MPs. (3) Novel membrane fusion techniques introduce inert footprinters into live cells
and native membranes for subsequent photoactivated footprinting. Our hypotheses are built on extensive
preliminary data. Three years of funding supported publication of 18 papers in high-profile journals. A significant
example describes laser activation of TiO2 nanoparticles attached to liposomes to generate high local
concentrations of radicals. Simultaneous membrane poration permits radical entry to footprint with sufficient
structural resolution that reports the ligand-binding sites and rocker-switch motions of GLUT1. Building on these
successes, we will pursue two specific aims: (1) develop new chemical probes for MS footprinting of MPs; and
(2) conduct comprehensive footprinting in native membranes and live cells to reveal anticancer drug interactions
and trafficking regulations of GLUT1. Our innovative footprinting coupled with bottom-up MS proteomics analysis
will establish bio-orthogonal footprinters that afford comprehensive coverage of both hydrophobic and hydrophilic
regions of MPs and reveal drug interactions and structural regulation of human MPs under inarguable native
settings. The impact of the proposed approach should readily expand because MS-based footprinting can be
broadly applied in structural proteomics to expedite drug discovery and structural studies of cellular processes.

Public health relevance
The proposed research is relevant to public health because our development of mass spectrometry footprinting methods will be broadly applicable for the study of human membrane proteins that represent more than 60% of the drug targets and participate in almost all physiological processes. We will apply new methods we develop in native membranes and live cells to reveal the interactions of a human glucose transport protein with anticancer drug candidates and partner proteins that regulate glucose levels in the human body.